A Flexible High-Throughput Immunological Assay to Support Next-Generation Influenza Vaccine Studies

Our objective is to develop better assays for measuring antibodies produced in people after influenza infection
or vaccination. We’ll develop assays that measure total antibody responses, and assays that specifically
measure the antibodies responsible for protection from infection. By using high-throughput multiplexed formats
employing reagents that can be prepared and stored in large lots, the assays will address many of the practical
limitations of current gold standard methods like the hemagglutination inhibition assay (HAI) and the viral micro-
neutralization (MN) assay. The assays will use the Meso Scale Diagnostics® (MSD) electrochemiluminescence
(ECL) assay platform, which has been widely adopted for qualification of COVID-19, pneumococcal and other
vaccines. The assays will use multi-well plates with arrays of influenza hemagglutinin (HA) in each well to
support the simultaneous measurement of antibodies against the strains represented in a vaccine, and to
analyze cross-protection against other strains of interest. A set of detection reagents and assay formats will be
developed that, when used with the antigen array component, will support a range of measurement modalities.
These include the measurement of (i) antibodies that block the ability of each antigen to recognize sialic acid
(SA) modified host proteins; (ii) total IgG and/or IgA against each antigen (in blood or respiratory samples); and
(iii) antibodies recognizing pre-selected universal epitopes. Through this work, we will provide important tools for
accelerating the development of new influenza vaccines.
The phased UH2/UH3 program will include the following main components. In the UH2 feasibility/early
development phase we will develop and optimize the required assay reagents needed to measure antibody
responses to 10 recent vaccine strains, as well as several historical human strains and potentially pandemic
avian strains. In this phase, we will also optimize the assay formats and assemble sample sets for later validation
work. In the UH3 validation phase, we will establish manufacturing procedures for producing assay kits to
conduct the proposed assay methods, and validate performance by testing well-characterized sample sets and
comparing our results to established gold standard methods.
†The sections on documents contained in this proposal that are marked with an asterisk contain proprietary/confidential information that MSD requests not be released to
persons outside the Government, except for purposes of review and evaluation.

Public health relevance
Our objective is to develop better assays for measuring antibodies produced in people after influenza infection or vaccination. We’ll develop assays that measure total antibody responses, and assays that specifically measure the antibodies responsible for protection from infection. The assays will be faster and more practical than existing methods, and will provide important tools for accelerating the development of new influenza vaccines. †The sections on documents contained in this proposal that are marked with an asterisk contain proprietary/confidential information that MSD requests not be released to persons outside the Government, except for purposes of review and evaluation.